Role of HLA Class-II Polymorphism in the Regulation of Host-Microbiota Symbiosis

Both HLA class-II polymorphism and gut microbiota had been linked with the regulation of host immunity and
pathobiology of multiple sclerosis (MS) However, it is not known whether there is a crosstalk between HLA
class-II molecules and gut microbiota in the regulation of host immunity which can influence disease outcome
in people with MS (PwMS). Thus, there is a critical unmet need to understand mechanism(s) through which
interaction between HLA class-II polymorphism and gut microbiota modulate disease phenotypes in MS. Our
long-term goal is to determine mechanism(s) through which gut bacteria and their metabolites influence
protection from or predisposition/progression to MS so that we can harness the enormous potential of gut
microbiome as diagnostic and/or therapeutic agent. Previously, we have utilized transgenic mice expressing
MS linked HLA-DR and -DQ alleles in experimental autoimmune encephalomyelitis (EAE), an animal model of
MS to validate the significance of HLA in MS. We have shown that while HLA-DR3 transgenic mice are
susceptible and HLA-DQ8 transgenic mice are resistant to EAE, the presence of HLA-DQ8 allele on a disease
susceptible HLA-DR3 transgenic mice (HLA-DR3.DQ8) results in severe disease. Our data showing that
cytokine and gut microbiota profile being more similar between HLA-DQ8 and HLA-DR3.DQ8 mice than HLA-
DR3 mice suggest a role of HLA-DQ8 restricted gut microbiota and Th17 response in modulation of disease.
Additionally, weaning reaction defined by a period in newborn mammals when expansion of gut microbiota
during early life induces a vigorous immune response, had been shown to play a critical role in maintaining
immune homeostasis through induction of immune imprinting. Based on these observations we hypothesize
that HLA class-II molecules modulate host immunity through regulation of host microbiome during early life and
adulthood and perturbation of the same might lead to predisposition/exacerbation of inflammatory disease
such as MS. We propose to determine the significance of HLA class-II polymorphism in disease resistance vs
susceptibility through its influence on neonatal and adult gut microbiota in two aims. In aim-1, we will determine
significance of HLA class II polymorphism in regulating adult gut microbiota and disease pathogenesis by
characterizing APCs and CD4+ T cells function (cytokine signature) in disease susceptible HLA-DR3 vs. disease
resistance HLA-DQ8 mice in conventional or pseudo-Germ-free mice (antibiotic depleted gut microbiota). We will
also perform microbiome transplantation from disease resistance to susceptible strain and vice versa or
colonization with specific bacteria identified in microbiome analysis to determine whether adult gut microbiome
alone can transfer the immune and disease phenotype. In aim-2, we will determine effect of HLA class II
polymorphism on the selection of neonatal gut microbiota and weaning reaction on immune-imprinting and
disease susceptibility to EAE in adulthood. We will determine the effect of early life gut microbiota in immune
response by characterizing CD4 T cell effector response, frequency, and function of regulatory CD4+ T cells and
APC function in conventional or pseudo-Germ-free mice (antibiotic depleted gut microbiota). Importance of early
life gut microbiota in modulation of EAE disease will be determined by cross-fostering of pups from disease
susceptible with lactating dams from resistant strain and vice versa to determine whether neonatal gut microbiome
alone can transfer the immune and disease phenotype. Successful completion of our study will help in determining
the significance of HLA class-II restricted gut microbiota during early life and adulthood on modulation of immune
response and EAE disease. This project has strong translational potential as it help to identify gut bacteria
linked with disease resistance vs susceptibility which can be used for the development of novel diagnostic,
prognostic and/or therapeutic target for MS. Since HLA class-II polymorphism and gut microbiota had been
linked with multiple autoimmune diseases, the data from our study will be useful for other diseases too.

Public health relevance
HLA class-II genes and gut microbiota had emerged as an important genetic and environmental factor linked with the pathobiology of multiple sclerosis (MS) a relevant medical problem faced by Veterans. However, the mechanism through which interaction between gene (HLA class-II) and environmental factor (microbiota) might predispose to or protect form MS is unknown. Thus, our proposal on understanding the mechanisms through which the HLA and gut microbiota can modulate disease in MS patients will be an essential step in that direction as a better understanding of the same might lead to discovery of novel treatment options.